Human Models of Selective Insulin Resistance

PROJECT SUMMARY/ABSTRACT
The twin metabolic pandemics of type 2 diabetes (T2D) and metabolic dysfunction-associated steatotic liver dis-
ease (MASLD) both appear to be rooted in hepatic insulin resistance (IR) and are characterized, respectively, by
unchecked hepatic glucose production (HGP) and de novo lipogenesis (DNL) of triglycerides (TG). However, the
pathophysiology of this high glucose + high TG phenotype remains unclear, as pure loss of function of the insu-
lin receptor decreases, rather than increases, DNL. Thus, the common (multifactorial) IR associated with MASLD
appears to be selective. We hypothesize that the insulin-signaling threshold for stimulating DNL is lower than
for inhibiting HGP, and so the compensatory hyperinsulinemia needed to maintain euglycemia also, counter-
productively, promotes excessive DNL. This concept remains controversial, but understanding insulin’s role in
the dual pathology of T2D and MASLD is essential to treating – or potentially even preventing – them both.
In this proposal, the PI (Dr. Joshua Cook) plans to prove the existence of selective IR in humans by taking
two independent approaches (Speciﬁc Aims 1 and 2) to demonstrate that high levels of insulin continue to drive
DNL even when the liver is resistant to insulin’s glucose-lowering eﬀects. Both Speciﬁc Aims will be carried out
in patients with MASLD and IR (prediabetic state + fasting hyperinsulinemia) in a randomized, placebo-con-
trolled, crossover design. In Speciﬁc Aim 1, subjects will receive a two-week course of the insulin anti-secreta-
gogue diazoxide (2 mg/kg per dose) versus placebo to directly lower insulin levels. In Speciﬁc Aim 2, hyperinsu-
linemic signaling will be blockaded by a single dose of the phosphoinositide-3-kinase inhibitor alpelisib (300
mg) versus placebo. In both cases, the PI will use stable isotope tracers to measure several aspects of hepatic TG
metabolism, including the primary endpoint of overnight (fasting) DNL, measured as incorporation of 13C-la-
beled sodium acetate into very low-density lipoprotein (VLDL) TG. The lipid-kinetic ﬁndings will be contextu-
alized by quantifying the degree of systemic IR resulting from the study treatments via the insulin suppression
test. Proving that hyperinsulinemia continues to drive DNL during IR would support future clinical trials of
“hyperinsulinemia reduction” as a novel therapeutic strategy for MASLD.
The proposed Speciﬁc Aims will be achieved under the guidance of an Advisory Commi^ee led by Drs.
Henry Ginsberg (Primary Mentor) and Blandine Laferrère (Co-Mentor), along with three Advisors possessing
expertise to germane to each of three Career Development Aims: Drs. Julia Wa^acheril (patient-oriented re-
search), Rebecca Haeusler (lipid kinetics), and Jaime Rubin (academic career skills). Columbia University is the
ideal institution for the PI’s research training, boasting world-class resources such as the Irving Institute for
Clinical and Translational Research, the Naomi Berrie Diabetes Center, and the Mailman School of Public Health.
This structured career development plan will enable Dr. Cook to become a R01-funded clinical investigator.

Public health relevance
PROJECT NARRATIVE The dual metabolic pandemics of type 2 diabetes (T2D) and metabolic dysfunction-associated steatotic liver disease (MASLD) share a common basis in insulin resistance (IR). However, IR in the liver appears to be selective: the compensatory hyperinsulinemia needed to overcome IR to restore euglycemia may drive hepatic triglyceride synthesis to excess. We will directly test the selective-IR model in humans for the first time, and thereby seek to demonstrate that liver “insulinization” imposes a tradeoff between controlling T2D and exacerbating MASLD.